ENHANCING LYSOSOME BIOGENESIS TO PREVENT AMYLOID PLAQUE PATHOGENESIS

ABSRACT The metabolism of amyloid precursor protein (APP) and amyloid-β peptide (Aβ) are critical determinants of Alzheimer's disease (AD) pathogenesis. APP is a type-1 transmembrane protein which resides in the plasma membrane. A fraction of APP undergoes endocytosis and is trafficked to late endosomes, where proteolytic cleavage by β- and γ-secretase results in the liberation of Aβ which is released into the extracellular space (interstitial fluid, ISF), even in normal individuals. Elevated levels of ISF Aβ may promote aggregation into soluble oligomers and insoluble amyloid plaques, and subsequent development of AD pathology. In addition to production, Aβ degradation and clearance significantly influences ISF Aβ levels and plaque pathogenesis. It has been postulated that age-related and disease-specific lysosomal dysfunction drives AD pathogenesis. While the specific underlying causes of lysosomal dysfunction continue to be unraveled, the resultant disease- promoting mechanisms may depend upon the cell type. For example in neurons, where Aβ is produced, physiologic lysosomal proteolysis may favor complete, non-amyloidogenic APP processing and/or Aβ degradation prior to release. In astrocytes, lysosomal activity may be important for catabolism of extracellular Aβ (and possibly amyloid fibrils) taken up intracellularly; while in microglia, it may promote clearance of the phagocytosed amyloid deposits. Understanding the role of cell-type specific lysosomal dysfunction in AD pathogenesis will be critical for identifying potential targets for intervention. Ubiquitously expressed Transcription Factor EB (TFEB), has been recently identified as a master regulator of lysosome biogenesis, endocytosis, and autophagy. While drugs are currently available (e.g., rapamycin) that stimulate autophagy, the TFEB-regulated transcriptional program coordinately increases flux through multiple lysosomal degradative pathways; and is sufficient to alleviate abnormal substrate accumulation and pathology in various lysosome storage diseases. Our preliminary data demonstrate that exogenous TFEB expression decreased Aβ production/release by N2a-APP695 cells (a neuroblastoma cell model of APP processing) compared with controls. In addition, TFEB expression in N2a cells resulted in increased uptake and accelerated degradation of exogenously applied Aβ. These data suggest that TFEB-induced lysosome biogenesis enhances APP and Aβ degradation through several cellular mechanisms. In this proposal, we hypothesize that enhancing lysosome biogenesis with exogenous expression of TFEB will suppress AD pathogenesis in a cell-type specific manner: in neurons, TFEB will facilitate complete proteolysis of APP and Aβ resulting in decreased Aβ generation and reduction in steady-state ISF Aβ levels; while in astrocytes, it will enhance Aβ uptake and degradation, resulting in reduced ISF Aβ half-life. Both mechanisms will attenuate amyloid plaque deposition. We will test this hypothesis in the following aims: 1. Determine the effect of TFEB-induced lysosomal biogenesis on APP processing and Aβ production in neurons. 2. Determine the effect of astrocytic expression of TFEB on Aβ and amyloid catabolism, and plaque growth.

Public health relevance
Public Health and Clinical Relevance Alzheimer's disease (AD) is the leading cause of dementia throughout the world. With the aging population, the prevalence of AD is increasing rapidly. Understanding how the metabolism of Aβ and APP lead to the disease will be important for developing potential therapeutic targets. This R21 grant proposes to study the role of lysosomal degradation pathways in Aβ and APP metabolism and the development of AD pathology.